Optimization of strategies to improve NCI-sponsored clinical trial participation throughout the Weill Cornell Medicine - Meyer Cancer Center Sphere

Optimization of strategies to improve NCI-sponsored clinical trial participation throughout the Weill
Cornell Medicine - Meyer Cancer Center Sphere
The Meyer Cancer Center (MCC) of Weill Cornell Medicine (WCM), and NewYork Presbyterian Medical
Center (NYP) is a matrix cancer center serving a catchment area of approximately 6 million diverse patients in
following locations: WCM, located in the Upper East Side of Manhattan, NYP Lower Manhattan (NYP-LM)
located in lower Manhattan south of Greenwich Village (with virtually all cancer care occurring at WCM), NYP-
Brooklyn Methodist Hospital (NYP-BMH), located in Park Slope, and NYP-Queens Hospital (NYP-Q), located
in Flushing. WCM was a long-standing main member of CALGB as well as COG, while also having full
member status including leadership within and participating in trials for RTOG, ECOG, and ACRIN. Most
recently, within the NCTN, MCC/WCM has predominantly been involved in the Alliance, including affiliate
membership at the NYP-BMH site and COG while continuing to have some leadership roles in NRG Oncology
(including main membership at the NYP-BMH site and affiliate status at the NYP-Queens site). WCM was a
founding member of the N01 funded NYCC, now participating in the ETCTN via Ohio State University.
The Research Specialist (Clinician Scientist) applicant Dr. Tagawa has been most intimately involved
with the NCTN via CALGBAlliance (serving as institutional PI since 2013). He has personally led and
mentored others across multiple disciplines and Departments in leading NCI studies. Within the MCC, the
applicant is co-Leader of the Experimental Therapeutics Program and primary leader of the GU Disease
Management Team across the MCC sphere. He is the top oncology accruer to NCTN studies within the MCC.
Since his arrival at WCM and as he took over leadership of the Alliance, NCTN accruals have increased
overall, as has minority accrual.
Most of his direct contributions to NCI clinical trials has come via leadership with the Alliance and
specific work within the GU committee. He has held a seat on the Board of Directors since 2013 and continues
to serve on various Alliance committees. Within the GU group, he has had several concepts move through the
Alliance, Task Force, GU Steering, and CTEP. He is now focused on mentoring others in this process, having
brought in investigators from multiple disciplines to the committee; for instance, he has mentored a radiation
oncologist who is now leading Alliance and NRG studies.
Dr. Tagawa plans to continue to expand the MCC NCI trial portfolio into Brooklyn and Queens. With
experience and leadership roles both within the Alliance and the MCC, he will leverage infrastructure that he
has built for prostate cancer clinical trials to grow the clinical research portfolio across other Disease
Management Teams, initially in Brooklyn, then Queens. The applicant stands poised to significantly increase
access to and participation in NCI-sponsored clinical trials across the diverse and underserved population
within the MCC catchment area.

Public health relevance
Optimization of strategies to improve NCI-sponsored clinical trial participation throughout the Weill Cornell Medicine - Meyer Cancer Center Sphere Narrative: The applicant Dr. Tagawa is MCC's PI for the Alliance, heavily involved in the GU committee, and serves on the NCI Prostate Cancer Task Force. He has personally led and mentored others in leading NCI studies, is a top NCTN accrual leader, and will continue to expand the MCC NCI trial portfolio into Brooklyn and Queens.